Wearable magnetoencephalography for studying parent-infant interactions

PROJECT SUMMARY
The proposed work will build on current wearable, optically pumped magnetometer-based
magnetoencephalography (OPM-MEG) methods our group has developed for use in infants, and will further
optimize this technology for simultaneous recording of brain activity in caregiver-infant dyads during naturalistic,
freely moving, social interactions. While both electroencephalography (EEG) and functional magnetic resonance
imaging (fMRI) have been used to assess brain function in infants, and EEG has been used to simultaneously
assess caregiver-infant dyadic brain function during social interactions, they each have limitations that are
addressed by wearable OPM-MEG. Both EEG and MEG allow for high temporal, millisecond, resolution;
however, EEG poses challenges for source localization. Although fMRI addresses the source localization issues
of EEG, it does not allow for the same naturalistic social paradigms as EEG, and is also loud and expensive.
OPM-MEG is non-invasive, quiet, and provides both high temporal resolution and accurate source localization.
Despite the strengths of OPMs, there are several outstanding challenges that include 1) optimization of source
imaging in caregiver-infant dyadic assessments, as well as 2) developing robust, motion-tolerant OPM-MEG
approaches for ambulatory hyperscanning. This proposal will address all of these challenges in caretaker-infant
dyads with 3-6-month-old infants, a group where unplanned movements are inevitable. Addressing these issues
in this population and paradigm will answer incredibly important technological questions in a context that will
translate to many populations where functional neuroimaging is needed to optimize diagnosis and treatment.
Further, the ability to assess brain function simultaneously within a dyad with lifespan compliance represents an
unprecedented opportunity to gain knowledge about social neuroscience, which is key to being able to recognize
clinically relevant patterns of brain function indicative of later emerging and current psychopathology. Once the
proposed work is completed, we will have developed optimized protocols, and the highest quality OPM-
MEG data ever collected in infants, as well as simultaneous caregiver-infant OPM-MEG collected during
naturalistic, physically-touching, social interactions. The innovations represented by this proposal are
paramount to moving the field of functional neuroimaging vertically to improve our understanding of
neurodevelopment and brain function using salient social interactions and paradigms requiring motion.

Public health relevance
PROJECT NARRATIVE The primary goal of this proposal is to further optimize and refine methods to collect the highest quality brain function data during naturalistic, freely moving behaviors using wearable optically-pumped-magnetometer magnetoencephalography (OPM-MEG) by addressing current obstacles to OPM-MEG hyperscanning in caregiver-infant dyads (a group where free motion during assessments is inevitable), including 1) optimization of source imaging in caregiver-infant dyadic assessments, and 2) developing motion-tolerant (standing, walking) OPM-MEG approaches for hyperscanning. This work will lay the foundation for innovative, hypothesis-driven research aimed at understanding both how these dyadic neural patterns change during normative development, as well as how we can use this technology for identifying functional brain patterns that are indicative of emerging risk for disorders across the lifespan, allowing for early identification and intervention.